Predicting neurodegeneration in living patients by IR imaging of skin fibroblasts

ABSTRACT
Although neurodegenerative diseases most often can be identified by late onset behavioral characteristics or
by post-mortem pathology, we often lack reliable methods to predict disease status early in life. It remains
extraordinarily difficult in many cases to make clear distinctions among neurodegenerative disease subtypes
before the onset of symptoms, or to determine when disease onset will occur. New biomarkers are needed.
We have developed a Fourier transform infrared (FTIR) spectromicroscopy approach to predict disease status
from cell images based on chemical endpoints. Cells are exposed to IR light and spectral phenotyping ofthe cell
images produces an absorbance signature as a rapid physiological indicator of disease state. We will test
whether the method can accurately classify disease status in the absence of behavioral or tissue abnormalities and
benchmark the predictions in mice with known disease features. In human cells, we will test whether the FTIR
biomarker can accurately predict neurodegenerative disease class using human patient fibroblasts and
lymphoblasts as surrogate cells. The FTIR spectrum will be tested to distinguish among neurodegenerative
subtypes that are often confused with each other, e.g., Alzheimer’s disease (AD) and non-AD dementias.
These proof of principle experiments are designed to establish whether the FTIR method can generate a
reliable early disease biomarker and whether the signature has the power to discriminate among distinct
disease subtypes.
1

Public health relevance
PROJECT NARRATIVE We will develop a reliable general-use method based on infrared imaging to predict neurodegenerative disease in living patients using surrogate cells (fibroblasts and lymphoblasts).